MIRA: Systems genomics of complex traits - Administrative Supplements to Support Undergraduate Summer Research Experiences

Project Summary:
The genotype-phenotype map in humans is shaped by complex interactions between multiple
loci and environmental factors, but the structure and function of these interactions remain poorly
understood. This lack of understanding limits our ability to predict and prevent individual
susceptibility to sickness and disease.
These interactions can generate pleiotropic effects that confound traditional knockout
approaches. Moreover, the genomic context can modulate these interactions both functionally
and evolutionarily. We aim to elucidate these questions using a systems-genetics framework
with three experimental paradigms in Caenorhabditis elegans and its relatives: (1) How do
complex regulatory systems evolve and function? (2) What are the sources and consequences
of genomic hyper diversity?, and (3) How do variation, recombination and sexual reproduction
affect evolutionary responses? We will employ an integrative approach that combines genomics,
single-cell analysis, microfluidic engineering, high-throughput phenotyping, genetic
transformation, and computational biology. This research combines a strong functional
hypothesis-testing framework with natural genetic variation to apply a systems-genetics
approach that helps understand the evolution and function of complex regulatory systems that
have critical implications for human health.

Public health relevance
PROJECT NARRATIVE Despite notable successes of identifying the genetic basis in some human diseases, most diseases are generated by complex interactions between multiple genes and the environment. Solving this problem requires a comprehensive systems approach in which variation and function at all genes is examined simultaneously in multiple environments, with particular focus on how the patterns of expression of these genes are regulated. Using natural populations of species with extreme genetic variation provides an opportunity to identify unique regulatory elements and systems whose functional impacts would otherwise be hidden to us.